Quasispecies dynamics in arbovirus persistence emergence and fitness

Arthropod-borne viruses (arboviruses) adapt to local conditions, maximizing their potential to perpetuate and
emerge as health threats. The adaptive potential of arboviruses is driven by error-prone replication, which
creates a genetically diverse pool of competing virus genotypes within each host. This proposal examines
some of the ways that temperature may impact arbovirus evolutionary biology. Our previous research has
allowed us to make clear predictions about the outcome of each proposed aim, and generated molecular and
computational tools, and methodological approaches that we propose to combine in this project.
Global temperatures are changing at an unprecedented rate, and RNA viruses such as WNV continue to
emerge at a frightening pace. Our preliminary studies have shown quite clearly that temperature is a key factor
that dictates how natural selection affects arboviruses within mosquitoes. Therefore, Aim 1 will address how
temperature, both constant and fluctuating, with varying means and amplitudes, alters natural selection on
WNV within mosquitoes and the strength of bottlenecks. Our predictions (in general) are that fluctuating
temperatures will increase the strength of purifying selection, that diversity will be maximized at optimal
constant temperatures, and that bottlenecks will become wider as temperature increases.
Our results have demonstrated that flavivirus infections are most frequently initiated by aggregates of virus
particles. Aim 2 will address the extent that this occurs in a host- and temperature-dependent manner, bringing
our previous work into a more ecologically relevant, realistic context. In the second phase of Aim 2, we will ask
whether these genome aggregates can help to facilitate the maintenance of genetic diversity in the WNV
population.
Birds that generate high WNV viremia and are highly infectious to mosquitoes have significantly more unique
WNV genomes per cell than those that have lower viremias. Aim 3 will assess whether something similar may
occur in mosquitoes. We will use barcoded WNV to infect mosquitoes with a range of vector competence and
assess the number of unique WNV genomes per cell. As above, we also will assess the degree to which this
phenomenon may allow for the maintenance of low fitness viral genotypes while preventing those of high
fitness from gaining dominance.
This work will provide comprehensive data on the ways that changing environmental conditions may alter the
fundamental population biology of arboviruses. Our work is also significant because it will provide mechanistic
data on how viruses may maintain genetic diversity in the face of both selective and stochastic reductions in
genetic diversity. The proposed studies are technically and conceptually innovative because of the ways that
we can combine realistic transmission systems in the lab with barcoded viruses, single cell approaches, and
other new molecular tools.

Public health relevance
In this project we will assess how temperature impacts selective and stochastic alterations to WNV populations during systemic mosquito infection. We also will explore how virus particle aggregates and infection of individual cells by multiple WNV genotypes may influence the amount and type of genetic diversity that is maintained in the virus population. This project leverages over 15 years’ worth of WNV and ZIKV research and makes innovative use of new molecular tools that we have developed as part of this project.